Supplement to promote diversity: From atoms to mechanisms - Artificial Intelligence augmented molecular simulations for mechanistic ligand design.

This is a request for research supplements to promote diversity in health-related
research for the PI Tiwary's R35 award titled From atoms to mechanisms - Artificial
Intelligence augmented molecular simulations for mechanistic ligand design. Through
this supplement, the mentee will work on two different but interconnected projects that
impact both Areas from the originally funded proposal. The key idea is to develop and
apply Graph Neural Networks (GNNs) based approaches in two different ways relevant
to practical drug design and computational biophysics.

Public health relevance
This diversity supplement will help develop sampling algorithms at the interface of statistical mechanics and artificial intelligence to probe mechanisms for rare event processes, such as drug unbinding and conformational change in drug targets. Through this supplement, the mentee will work on two different but interconnected projects that impact both Areas from the originally funded proposal. The key idea is to develop and apply Graph Neural Networks (GNNs) based approaches in two different ways relevant to practical and cost-effective drug design and computational biophysics.